Modulation of Monocyte and T Cell Functions by Immune Inhibitory Receptors during Subclinical Malaria

ABSTRACT
Subclinical Plasmodium falciparum (Pf) malaria involves the tolerance of parasitemia without development of
fever or overt symptoms. Individuals with subclinical malaria are a reservoir for ongoing transmission and are
therefore an important target population for malaria elimination strategies. The immunoregulatory mechanisms
that permit subclinical Pf infections remain poorly understood. Evidence suggests that immune inhibitory
signaling pathways are key to maintaining a sufficient balance between protection from immunopathology while
limiting parasite replication. We propose to study the impact of inhibitory receptor signaling on monocyte and T
cell functional interactions during transient vs. chronic subclinical malaria in children. We will focus on the role of
inhibitory receptors Leukocyte Immunoglobulin Like Receptors B1 (LILRB1) and LILRB2. Our preliminary data
show that malaria infections are associated with increased expression of LILRB1 and LILRB2 on monocytes in
young children, and engagement of these receptors impairs innate immune cells’ ability to activate T cells. We
will leverage already-collected samples from a longitudinal cohort of Beninese children aged 1-15 years to test
our central hypothesis that inhibitory receptor signaling in monocytes constrains innate immune functions and
suppresses T cell activation during chronic subclinical malaria. In Aim 1, we will (i) define the immunoregulatory
phenotypes, including surface expression of co-inhibitory and co-stimulatory receptors on monocytes and T cells,
(ii) determine monocyte function following in vitro stimulation and (iii) perform monocyte and T cell transcriptomic
analysis (scRNAseq and RTqPCR). We will compare those data between Pf-uninfected children vs. transient
subclinical malaria vs. chronic subclinical malaria vs. children with clinical malaria. In Aim 2, we will account for
host and parasite factors that may also influence immunoregulatory phenotypes. HLA-G (HLA class I molecule)
is a soluble host protein that binds to LILRB1/B2. Level of HLA-G is known to increase during acute malaria.
Certain members of the rif multigene family (encoding RIFINs) have recently been shown to bind to LILRB1 and
LILRB2, acting as a mimic of HLA-G. Levels of HLA-G and RIFIN variants and their impact on innate immune
cellular functions have not been explored in subclinical malaria. We will decipher HLA-G/RIFIN/LILRB interplay
and their association with transient and chronic subclinical malaria. These results will further our understanding
of naturally acquired immunity and can be used to inform malaria vaccine strategies.

Public health relevance
NARRATIVE Individuals with subclinical malaria are a reservoir for ongoing malaria transmission and are therefore an important target population for malaria elimination strategies. Identification of the immunoregulatory mechanisms that mediate parasite tolerance will improve our understanding of how clinical immunity is acquired and maintained. These results can be used to inform malaria vaccine development.